Understanding the neurocomputational mechanisms underlying speech sensorimotor adaptation

Project Summary
Sensorimotor adaptation, learning from the mismatch between the predicted sensory feedback of our
intended motor action and the actual sensory feedback we observe, is a fundamental skill that supports accurate
movement control, such as speech. One common paradigm used to study the mechanisms of speech adaptation
is examining how speakers adjust their speech production in response to an external perturbation applied to the
auditory feedback of their speech acoustics in real time. While this paradigm has been proposed as a tool to
assess the mechanisms of speech deficits in various neurogenic disorders, reduced speech adaptation is
commonly found across various clinical populations, despite impairments in very different neural structures. This
pattern is not well-predicted by the current models of speech motor control, potentially because speech
adaptation may not involve a single learning process (as in current models) but, as suggested by extensive work
in other (nonspeech) motor domains, two distinct processes – a fast process that learns quickly from error but
retains less, and a slow process that learns slowly but retains more.
Here, we test the hypothesis that adaptation in speech, like in other motor domains, involves separable
fast and slow processes by translating a behavioral paradigm known to uncover multiple learning processes
across motor domains to speech for the first time (Aim 1). Separately, we will test the neurocomputational basis
of adaptation by combining this novel behavioral paradigm with continuous theta-burst transcranial magnetic
stimulation to temporarily inhibit regions known to affect adaptation (Aim 2). By assessing behavioral correlates
of both fast and slow processes after stimulation, we can separately assess which regions are involved in each
process. We test this both in speech and, as a control, in reaching, which is known involved both the fast and
slow processes. As the neural networks underlying these separate processes in reaching have not been well
established this work additionally provides the first assessment of the neurocomputational basis of adaptation
across multiple motor domains, allowing us to test the domain generality of the two-process model of adaptation.
Even in the case that we only find a single adaptation process in speech, comparison of the neural findings in
speech and those in reaching allows us to test whether the neural substrate underlying speech adaptation maps
onto the analogous regions involved for the fast or slow process (or both) in reaching. This research will improve
our understanding of the computational processes in speech adaptation and refine the neural mechanisms of
sensorimotor adaptation across all motor domains. This work will provide a first step towards developing more
sensitive measures that can differentiate control deficits through speech adaptation which may help the
development of speech therapy that precisely targets the mechanisms of speech deficits across various clinical
populations.

Public health relevance
Project Narrative Sensorimotor adaptation, learning from sensory feedback, is a fundamental skill that supports accurate movement control in speech and is impaired in many neurogenic disorders (including cerebellar degeneration, Parkinson’s disease, and adults who stutter). However, why such damage to such disparate neural structures leads to similar impairments in learning is not well understood, potentially because adaptation in speech may comprised of multiple learning processes, as has been shown in other types of movement such as reaching. The proposed studies expand a well-studied computational mechanism of sensorimotor adaptation to speech and test its neural basis across multiple motor domains, to providing a critical first step towards developing more sensitive measures that can differentiate control deficits in various neurogenic disorders which may help develop effective speech rehabilitation paradigms that target specific deficit mechanisms.